Addressing ClimaTe Change FOR IMPROVED CLEAN COOKSTOVE Uptake, Household Air Pollution Reduction, and Hypertension Prevention (ACT4ICC)

Abstract
The Community Mobilization for Improved Clean Cookstove Uptake, Household Air Pollution Reduction, and
Hypertension Prevention (R01HL157091) (CF-CS) parent study is an ongoing type-2 hybrid design
implementation trial that examines the role of community mobilization in household air pollution (HAP) reduction
and blood pressure (BP) control in 32 peri-urban communities of Lagos, Nigeria. In response to NOT-HD-23-
006, we propose this administrative supplement, Addressing ClimaTe Change FOR IMPROVED CLEAN
COOKSTOVE Uptake, Household Air Pollution Reduction, and Hypertension Prevention (ACT4ICC). ACT4ICC
will leverage Local Government Area (LGA) teams (particularly the environmental health officers that work
closely with the communities) to collect and monitor black carbon (BC) concentrations across all participating
households (experimental and control arms) and include its effects in the parent study analysis of HAP on BP
control. Additionally, ACT4ICC will build the epidemiological capacity of local authorities, to facilitate the
reduction in HAP in households and improve BP outcomes. Expansion into this area of monitoring and assessing
the effects of BC concentrations in the study population on BP, and epidemiological capacity building will allow
us to comprehensively understand and contextualize the effect of BC, which is known to be major components
of HAP with associations with high BP, and the role of local key players in environmental health management of
Lagos. CF-CS parent study is currently in the implementation phase and has begun recruitment. In addition to
engaging in the proposed climate and health research, ACT4ICC will build epidemiological capacity among local
environmental partners through training in data collection and monitoring of BC concentrations, engaging
stakeholders, interpreting findings, and integrating this new knowledge into practical strategies to potentially
scale climate change and health initiatives in LMICs.
Per instructions in to NOT-HD-23-006, this supplement is specific to climate change and health.

Public health relevance
NARRATIVE Black carbon (BC) is a major component of HAP and its exposure is associated with high systolic and diastolic blood pressure. This project, Addressing ClimaTe Change FOR IMPROVED CLEAN COOKSTOVE Uptake, Household Air Pollution Reduction, and Hypertension Prevention (ACT4ICC) study, collects and monitors BC concentrations in 32 per-urban communities of Lagos, Nigeria, and assesses their impact on BP. Additionally, this supplement builds the epidemiological capacity of local environmental agencies of Lagos by engaging key local environmental stakeholders and providing appropriate training in data collection and monitoring of a major household air pollutant in the country.